Efficacy and Mechanisms of a Metacognitive Strategy Intervention for Parkinson disease-related Cognitive Decline

PROJECT SUMMARY/ABSTRACT
The long-term goal of this research is to reduce disability, improve quality of life, and delay dementia onset
among people with Parkinson disease (PD) by enabling them to cope with cognitive decline so they can
perform and participate in meaningful activities and roles. Cognitive impairment is one of the most common
and disabling features of PD and is a major management challenge and area of unmet need. Surgical and
pharmacological treatments have proven largely ineffective in addressing this pressing burden, so behavioral
interventions that attenuate the negative functional consequences of PD-related cognitive decline are a top
research and clinical priority. Unfortunately, the widely used cognitive training approach to cognitive
intervention (repetitive practice of tasks designed to challenge and improve specific cognitive functions) has
been unsuccessful in improving daily function and quality of life in people with PD. To overcome this limitation,
the investigators take a strategy training approach, teaching targeted strategies that people can use in their
everyday lives to circumvent cognitive deficits and accomplish daily tasks. Strategy training is a practice
standard for cognitive rehabilitation in brain injury and stroke, but its application in PD is novel. Moreover, the
strategy training intervention used in this study, the Multicontext (MC) Approach, explicitly focuses on
generalization of training to daily function, an aspect that is critically lacking from PD-related cognitive
intervention research to date. Through rigorous and systematic development and pilot testing, the
investigators have fully specified and manualized the MC Approach, developed therapist training procedures,
and shown that is acceptable to participants, feasible to administer with high fidelity in real-world treatment
settings, and associated with clinically meaningful improvements in daily cognitive function. The primary
objective of the current project is to determine the efficacy of the MC Approach for improving daily cognitive
function in people with PD and mild cognitive decline. It is an assessor-blind randomized controlled trial
comparing the short-term and long-term effects of the MC Approach to a traditional cognitive task training
approach on personalized functional cognitive goals (Aim 1). Additional aims are to examine whether booster
treatment enhances MC Approach treatment effects (Aim 2) and explore the cognitive-behavioral mechanisms
of the MC Approach (Aim 3). This work will meet the pressing need for evidence-based and implementable
interventions that reduce functional impairment associated with PD-related cognitive decline and potentially
delay dementia onset in this population. Ultimately, it will improve clinical care for the growing number of
people living with PD and reduce the socioeconomic burden of this disease.

Public health relevance
PROJECT NARRATIVE Cognitive decline in Parkinson disease (PD) causes disability and reduced quality of life. Current medical treatments do not prevent or treat cognitive decline in PD, so behavioral interventions that mitigate its negative functional consequences and thus potentially delay the onset of dementia are in high demand. This study will test the efficacy of a targeted strategy training approach for improving cognition and daily function in people with PD and may ultimately result in enhanced independence and quality of life for this population.